UW 4-Dimensional Genomic Organization of Mammalian Embryogenesis Center

Project Summary / Abstract
A major shortcoming of most efforts to understand the 4D nucleome is that they have mainly focused on in vitro
cell lines, rather than on dynamic, in vivo systems. Arguably, the most important in vivo system, which also
happens to be the most dynamic, is development itself, wherein the nucleome both shapes and is shaped by the
initial emergence of the myriad mammalian cell types. While these in vivo dynamics are presently poorly
documented and understood, recently emerged technologies offer a path forward. Here we propose to establish
the University of Washington 4-Dimensional Genomic Nuclear Organization of Mammalian Embryogenesis
Center (UW 4D GENOME Center), which will address these massive gaps in our understanding by generating
systematic datasets on nuclear morphology and associated molecular measurements in mammalian tissues and
cell types. These datasets will be generated in the context of the leading model organism for mammalian
development, the mouse. Our approach focuses on following nuclear structure, chromatin and gene expression
changes at a “whole organism” scale, using a combination of scalable single cell profiling and “visual cell sorting”
(VCS) methods, all well-established and mostly developed in our own labs. Our goal is to generate a high-
resolution 4DN atlas of mouse embryogenesis for the community. The different types of data will be integrated,
including cross-species imputation to integrate with human data, as well as models and navigable maps applied
to pathways relevant to mammalian development.

Public health relevance
Project Narrative The UW 4D Genome Organization of Mammalian Embryogenesis Center (UW 4D GENOME) aims to elucidate chromatin dynamics during the early stages of mammalian development. Accordingly, the proposed center will carry out systematic generation of sequencing and imaging data during mouse embryogenesis, summarizing and visualizing the resulting data using machine learning models. These approaches will also be applied to investigate nuclear architecture in mouse models with mutations in genes relevant to nuclear structure, which will help advance our understanding of diseases such as laminopathy and cancer.